Modulating gene expression by RNA-targeting chimeras

Project Summary
RNA-binding small molecules have the potential to modulate the expression of genes whose protein products
were previously considered “undruggable.” Risdiplam, targeting a precursor mRNA, was recently approved for
the treatment of spinal muscular atrophy (SMA) and demonstrates the specificity and safety attainable by this
approach. Although a variety of small-molecule scaffolds have been uncovered as RNA-binding ligands, their
use is hampered by (1) lack of specificity and (2) unpredictable function. We propose a research program that
will provide RNA-targeting chemical probes that will avoid these drawbacks. Inspired by Proteolysis Targeting
Chimera (PROTAC) technology, we are designing chimeric molecules that will target RNA specifically and
carry (deliver) the ability to induce RNA degradation or inhibit RNA translation, in a highly predictable manner.
Our initial efforts towards an RNA-targeting chimera platform use a newly discovered RNA-binding coumarin
derivative as a model and fine-tune its preferential binding properties through chemical modification. Through
structural optimization, which includes using a “bidentate” RNA ligand strategy, we expect to achieve RNA-
binding selectivity equal to or greater than that of oligonucleotides. At the same time, we propose to develop
and optimize three novel effectors to precisely degrade RNA targets or inhibit the target RNA translation.
These new effectors have shown promising results in inhibiting Zika virus (an RNA virus) gene expression.
Ultimately, our proposed work will generate a top-down method for designing selective gene expression
inhibitors that are independent of the gene's protein product. The long-term goal of our lab is to build a
medicinal chemistry platform for making gene-specific and patient-specific therapies using RNA-binding small
molecules. In this process, we will not only generate various tool compounds for studying important disease-
modifying genes, but also combine computational and experimental technologies to understand the detailed
mechanism of RNA-small molecule recognition.

Public health relevance
Project Narrative Despite decades of research in academia and the pharmaceutical industry, we currently have very few small molecule ligands that can address RNA selectively and elicit useful biological effects. This leaves a tremendous portion of cellular biochemistry and metabolism outside of our control. We are tackling this challenging problem by using computer-assisted drug design to develop novel RNA-targeting chimeras to control RNA stability and RNA splicing during the translation of disease-modifying genes.